Exploiting bacterial effector proteins to study human ubiquitin signaling

Project Summary
Post-translational signaling through ubiquitination is essential to all eukaryotic life, and dysregulation of this
process can lead to severe forms of disease. The far-reaching importance of ubiquitin signaling across many
cellular processes stems from its ability to form a diverse set of polymeric chains that signal for distinct outcomes.
The complexity of ubiquitin signaling vastly outweighs our understanding of its regulation and cellular outcomes.
While the signaling roles for some ubiquitin chain types are known (e.g. protein degradation or cell cycle
regulation), the functions of many so-called `atypical' chains have remained a mystery despite decades of
research. As an alternative approach to studying fundamental human biology, we study the interactions between
invading pathogenic bacteria and the host ubiquitin signaling network. In addition to a range of other ubiquitin-
targeted activities, to support infection bacteria have evolved secreted effector proteins to assemble and remove
host ubiquitin signals, in some cases with exquisite specificity toward discrete ubiquitin chain types. We propose
that ubiquitin-targeted bacterial effectors represent a rich opportunity to study human ubiquitin signaling from an
`outside-in' perspective. To explore this opportunity, we have developed a multipronged approach that has
identified novel ubiquitin-targeted activities among important bacterial pathogens. Using structural and
biochemical approaches we will explain the mechanisms and specificities of these bacterial enzymes, at which
point they will be used as case studies and tools to extend our work toward deciphering the regulatory and
signaling complexities of the human ubiquitin system. Our innovative approach to studying ubiquitin biology plays
to our strengths in the biochemical mechanisms of its regulation, and leverages the strong evolutionary pressure
placed on bacteria to usurp specific aspects of host ubiquitin signaling. Over the next five years we will
demonstrate the breadth of bacterial ubiquitin-targeted activities and their utility for dissecting the intricacies of
ubiquitin signaling, which feeds into our larger vision of understanding the motivations and ramifications of
bacterial interference in host signaling processes.

Public health relevance
Project Narrative The signaling molecule ubiquitin controls many aspects of human biology. Despite its importance in numerous human diseases, the intricacies of how and where ubiquitin serves a signaling role are unknown. We study the means through which disease-causing bacteria hijack the ubiquitin signal as an approach to understanding its function in regulating human health.